TASK ORDER AWARD. CHEMISTRY, MANUFACTURING AND CONTROLS AND RELATED SERVICES FOR DEVELOPMENT OF DRUG SUBSTANCES. 3-YEAR STABILITY STUDY EXTENSION ON THE PTH-IA CGMP BATCH

The National Center for Advancing Translational Sciences (NCATS), through its Therapeutics for Rare and Neglected Diseases (TRND) program, is collaborating with the Massachusetts General Hospital (MGH) to evaluate [Leu11,dTrp12,Trp23Tyr36]-PTHrP(7-36)NH2 (PTH-IA) peptide as a potential treatment for Jansen Metaphyseal Chondrodysplasia (JMC). JMC is a rare disease of skeletal development and mineral ion homeostasis. Therapeutical Development Branch (TDB) in NCATS is responsible for the late-stage pre-clinical development toward an Investigational New Drug (IND) application and clinical testing of the PTH-IA.
One cGMP lot of PTH-IA acetate have been acquired by TDB to support the preclinical safety evaluation. The purpose of this contract is for TDB/NCATS to acquire an additional 150 GN (on net peptide basis) of cGMP PTH-IA acetate to allow for additional studies to be conducted, and to conduct a three year stability study of the cGMP batch. Under this task order, the contractor will be responsible for producing a 150 GN Current Good Manufacturing Practices (cGMP) lot of PTH-IA peptide, generate a CMC report in eCTD format, and conducting 3-year stability studies of PTH-IA peptide GMP batch (per ICH guidelines) using developed and validated stability-indicating analytical methods.
PTH-IA peptide structure:
H-Leu-Leu-His-Asp-Leu-dTrp-Lys-Ser-Ile-Gln-Asp-Leu-Arg-Arg-Arg-Phe-Trp-Leu-His-His-Leu-Ile-Ala-Glu-Ile-His-Thr-Ala-Glu-Tyr-NH2
or
LLHDLXKSIQDLRRRFWLHHLIAEIHTAEY; X = dTrp
The counter ion: acetate